EFFICACY, SAFETY, TOLERABILITY OF SR57746A IN ALS PATIENTS

This study is an industry sponsored study. Its aim is to study the efficacy, safety and tolerability of SR 57746A in patients with Amyotrophic Lateral Sclerosis (ALS).